Ukubandakanya abesilisisa: HIV self-testing for Partners of HIV-uninfected Postpartum Women to facilitate PrEP and ART uptake to promote HIV treatment and prevention

PROJECT SUMMARY
Perinatal women in South Africa (SA) have one of the highest HIV infection rates in the world, and are almost
exclusively infected via sexual contact from male partners. The postpartum period is an increased time of risk
for HIV. If women become HIV infected at the end of pregnancy or during the postpartum period, HIV may be
transmitted to the infant via breastfeeding. Women and men in partnerships in SA do not always know each
other’s HIV statuses. This can make HIV prevention difficult, particularly in SA, where men are less likely to be
tested for HIV than women. HIV-uninfected women have the option of using pre-exposure prophylaxis (PrEP)
to help them remain HIV-uninfected; men with HIV (MWH) who know their status, and who take treatment
effectively, are unlikely to transmit HIV to their female partners. Men are now able to test themselves for HIV
using HIV self-test (HIVST) kits; use of these kits has the potential to circumvent barriers to traditional, clinic-
based HIV testing, such as concerns about stigma or privacy, or competing demands, like busy work
schedules. Our earlier work suggests that men are willing to engage in behaviors to protect their female
partners from HIV during attempts to conceive in order to protect their offspring, including HIV testing.
Providing HIV-uninfected women with HIVST kits for male partner distribution and HIV prevention counseling
during the early postpartum period may help women remain HIV-uninfected during this time of increased risk,
and may also identify MWH and help those men engage in HIV care. Thus, this study has the following
objectives: (1) to refine the content of a combination intervention to promote HIVST for Partners and PrEP
uptake for HIV-uninfected Postpartum Women (“H4P”) via focus group discussion feedback from women and
men in SA who have had a child in the past year (N = up to 10 women and 10 men); (2) to conduct a
randomized pilot trial of the H4P intervention for postpartum HIV-uninfected women (N = 60 and their male
partners) in KwaZulu-Natal, SA, who report a partner of unknown serostatus. All women will receive HIVST kits
and standardized health information for distribution to male partners; those randomized to the H4P intervention
arm will also receive PrEP uptake counseling, and male partners will receive reproductive health-centered
information about why HIV testing is important. Feasibility and acceptability will be assessed. (3a) To evaluate
preliminary effectiveness by calculating, across intervention/control arms at three months post-intervention, the
proportion of women initiating PrEP among those whose partners test positive, do not test, or do not share a
test result, and the proportion of men with a positive test who link to HIV care. (3b) To conduct individual
qualitative interviews with a subset of enrolled women and their partners (N = up to 10-15 women and men) in
the intervention arm to explore opportunities to optimize the intervention.

Public health relevance
PROJECT NARRATIVE In South Africa, postpartum women and their infants are at especially high risk for HIV; HIV self-test (HIVST) kit distribution to postpartum women can serve as a catalyst for conversations about postpartum HIV prevention plans (including pre-exposure prophylaxis, or PrEP; learning their partners’ HIV status; and helping partners connect to treatment), as they transition to a period of less regular HIV testing. HIV self-test (HIVST) kits are a novel means by which to help couples prevent HIV. This study will evaluate the feasibility, acceptability, and preliminary effectiveness of a multi-step PrEP uptake and HIVST kit intervention for postpartum women who report a partner of unknown serostatus and their partners in KwaZulu-Natal, South Africa.